Polycystic Kidney Disease: Basic, Translational, and Clinical Science

[unreadable] DESCRIPTION (provided by applicant): [unreadable] [unreadable] This application seeks support for a meeting sponsored by the Federation of American Society of Experimental Biologists that will be focused on Polycystic Kidney Disease. The purpose of this meeting is to gather basic, translational and clinical scientists in a common meeting to share the latest findings in the field of polycystic kidney disease. This is the third PKD meeting sponsored by FASEB and it has commitments from 52 speakers to attend the meeting. Of the 52 speakers, one fourth will be new/young investigators. The goals of this meeting are to; 1) present recent advances in defining genes, molecular signaling pathways and pathogenic mechanisms involved in renal cystic diseases, 2) Evaluate how basic mechanisms may provide insights into developing novel therapies and biomarkers, 3) Provide a program that integrates basic, applied and therapeutic themes so physician-scientists, basic researchers and clinicians sharing this information can frame new experimental challenges and pressing experimental questions. [unreadable] [unreadable] [unreadable]